Data & Analytics Core

Project Summary/Abstract (Data & Analytics Core)
The Data & Analytics Core supports the overall mission of the Indiana Diabetes Research Center (IDRC) to
promote cutting edge research in diabetes and related metabolic disorders; foster collaboration; and support
training by offering state of the art computational and informatics services for large and/or multidimensional
datasets. Our services align with the NIDDK’s Strategic Plan for Research by: (1) developing and sharing
innovative computational technologies and data resources to facilitate the scientific progress of IDRC
investigators and to enhance the health of the communities we serve; (2) optimizing clinical research tools and
resources for the analysis and planning of clinical studies; and (3) improving dissemination and implementation
of evidence-based strategies to improve health. Formed in 2023, the overall goal of the Data & Analytics Core
is to unlock the diabetes research and discovery potential of ‘omics and real-world electronic health record
(EHR) data. The ‘omics-related services of the Core are built on the overwhelming success of a pilot program
to provide diabetes-focused bioinformatics services, which was housed in the IDRC Translation Core from
2020 until the establishment of the Data & Analytics Core. The EHR-related services of the Core complement
long-standing EHR data assets and services housed at the Indiana University School of Medicine by providing
diabetes-specific and tailored support to basic and clinical scientists in the IDRC. The long-term goals of the
Data & Analytics Core are to facilitate the incorporation of advanced data analysis techniques into IDRC
researchers’ projects and to educate our research community on new and emerging methods to advance our
understanding of molecular and environmental contributors to human health and disease. Drs. Mosley and
Harle are the Co-Directors of the Core, and Dr. Wu is the Associate Director. The Data & Analytics Core closely
interfaces with the IDRC Translation, Microscopy, and Islet & Physiology Cores to meet the experimental
needs of our User base, while adhering to the highest standards of rigor and reproducibility. The Data &
Analytics Core will achieve the following aims:
(1) Facilitate understanding and interpretation of investigator-generated “omics” datasets and translate
this complex information to actionable experimentation.
(2) Create and facilitate use of real-world EHR datasets that support translation of findings from model
and preclinical systems findings to humans.
(3) Facilitate access to, training in, and reuse of existing datasets that can be utilized to support the
work of IDRC investigators.